Deep Pathological Phenotyping in Frontotemporal Dementia and Motor Neuron Disease.

Abstract
This project seeks to perform deep pathological phenotyping of frontotemporal dementia (FTD) and motor
neuron disease (MND). The rationale for the proposal is that, despite the exploding basic biology of FTD
and MND, limited information is available about the strongest biological predictors of neurodegeneration
in the brains of patients. Even less is known about mechanisms underlying the striking selective
vulnerability seen in FTD and MND or what drives the clinico-anatomical overlap of the two disorders.
We will pursue these questions with a focus on TAR DNA-binding of 43 kDA (TDP-43) pathobiology, its
relationship to other emerging FTD/MND mechanisms, and its targeting of specific neuronal subtypes
within the FTD- and MND-related systems. We will further evaluate the complex neuropathological profile
seen in C9ORF72 expansion-related FTD/MND and build datasets equipped to help determine which
among the many pathological features in sporadic and C9-FTD/MND represent the strongest predictors
of neurodegeneration. Our approach seeks to overcome existing methodological barriers by combining
advanced histology, a novel tissue multiplexing platform that allows dozens of protein or RNA markers to
be quantified in situ, and single nucleus transcriptomics. We will study patients across the FTD/MND-
TDP-43 spectrum, including those with the C9ORF72 expansion, and control subjects. We aim to: (1)
Relate TDP-43 pathobiology to nuclear transport defects, cryptic exon incorporation, and DNA damage,
(2) Determine the pathological changes most prevalent in vulnerable neurons and regions and most
strongly linked to neurodegeneration, and (3) Identify transcriptional signatures of neuronal vulnerability
and TDP-43 pathobiology in FTD/MND. Successful completion of the proposed aims would resolve key
questions about the human relevance of candidate pathogenic mechanisms in FTD/MND-TDP, enabling
more informed prioritization of potential targets for human therapeutic development. The integrated
multidimensional data produced would create a deep library for testing new hypotheses as they emerge
and for generating new hypotheses. Finally, accomplishing our goals would advance a transformative
new histopathological approach to studying neurodegenerative and other complex human diseases.

Public health relevance
Project narrative This project seeks to comprehensively characterize the neuropathology of frontotemporal dementia and motor neuron disease. We will evaluate emerging mechanistic hypotheses for their relevance to human disease, explore mechanisms of selective neuronal vulnerability, and generate novel hypotheses about disease pathogenesis that can be tested in model organisms. We will pursue these goals using advanced histological methods, a novel multiplexed immunofluorescence platform, and single nucleus RNA sequencing to profile neuropathological changes and transcriptome abnormalities and link them to neurodegeneration across cell types and brain regions. If successful, this research could lead to better treatments for patients with frontotemporal dementia and motor neuron disease and could change the way neuropathological studies are used to understand disease pathogenesis.